Predoctoral Training in Multifaceted Translational Approach to Mental Illness

Mental disorders are among the most common causes of disability, and the disease burden is among the highest
of all illnesses. Thus, there is an urgent need to develop not only novel therapeutic approaches but also the next
generation of research scientists who can meet the challenges of the growing field of mental health research.
The overarching goal of this “Predoctoral Training in a Multifaceted Translational Approach to Mental Illness
(AMI)” program (Adrienne Lahti, MD, and Yogesh Dwivedi, PhD as Directors) is to provide the students with an
environment of cross-cultural training where they will be exposed to the clinical challenges, biological
mechanisms, and cutting-edge research approaches used across mental illnesses, rather than the kind of single-
disease training they might obtain by working in an individual research laboratory. The AMI T32 training program
will uniquely provide an interdisciplinary training environment that will integrate basic and translational research
training of predoctoral students to foster the development of critical thinking, communication, and in-depth
research skills. Built on a strong foundation and supported by a large infrastructure of outstanding basic,
translational, and multidisciplinary programs in mental health research, the AMI training program will take
advantage of interdisciplinary mental health research investigative efforts led by strong, internationally renowned
clinical and educational resources within the UAB Department of Psychiatry, dynamic mental health research
efforts by the Comprehensive Neuroscience Center, university-wide interdisciplinary initiatives of the UAB
Depression and Suicide Center, the Comprehensive Center for Translational Sciences, and UAB graduate
programs within the thematically based Graduate Biomedical Sciences and the Psychology Doctoral Program
affiliated with the Department of Psychology. The collaborative environment at UAB, embodied by various cores,
centers, programs, and departments, will provide extensive support for invigorating research efforts. The training
program is requesting three predoctoral training slots per year and will take advantage of well-established best
practices for the successful recruitment of underrepresented minorities and individuals with disabilities. The plan
will include required didactic courses, laboratory and clinical research, journal clubs, seminars, scientific
presentations both locally and at national meetings, and training in the responsible conduct of research. Trainees
will also benefit from courses on grant writing and professional skills development. Together, the trainee and
mentoring team will craft an individual development plan. Internal and External Advisory Committees will
evaluate the overall performance of the AMI training program. A series of benchmarks for progress will be
formulated for each trainee and mentor and reviewed on a semi-annual basis. As a top 25 NIH-funded academic
medical center with state-of-the-art scientific core facilities and university-wide, interdisciplinary research centers,
the University of Alabama at Birmingham is remarkably well-positioned to cultivate a new generation of
translational scientists who will advance and transform mental health research.

Public health relevance
This “Predoctoral Training in a Multifaceted Translational Approach to Mental Illness (AMI)” program is focused on providing training to highly motivated pre-doctoral students in the field of translational research in mental health. UAB has a large base of interdisciplinary faculty with interests centered in basic and clinical research, therapeutics and biomarkers, as well as genetics and functional genomics in the area of mental health. With the NIMH supported T32 program, our highly trained faculty, with the support of diverse resources and an enriched environment, are committed to provide an exceptionally strong mentoring framework to train the next generation of mental health researchers.